Genetic and single-cell multi-omic characterization of Alzheimer's disease risk and resilience pathways

Project Summary
Alzheimer’s disease (AD) is a devastating and complex neurodegenerative disorder with a crushing social and
economic burden currently affecting more than 6 million patients in the US. With the number of affected individu-
als projected to increase, identifying disease-modifying treatments and interventions for AD remains one of the
most critical undertakings in modern biomedical research. A critical step to the development of these interven-
tions involves characterizing the genes and pathways mediating AD risk and resilience. The objective of this
proposal is to explore the modulation of AD genetic risk by age and examine how caloric restriction (CR),
a lifespan-increasing intervention, can be harnessed to counter AD risk. The proposal will utilize state-of-
the-art single-nuclei multi-omic functional genomic analyses of healthy and AD human brain tissue, as well as
transgenic AD mouse models, to perform deep molecular characterization of AD risk and resilience across the
genetic, epigenomic, and transcriptomic layers. Aim 1 will dissect non-coding AD genetic risk through intensive
multi-omic molecular profiling of healthy and AD brains, allowing the nomination of causal variants, cell types,
and pathways mediating risk. Aim 2 will identify protective mechanisms in cognitively healthy, long-lived individ-
uals, including centenarians, and determine whether AD resilience manifests by maintaining a “young” state or
by compensating for detrimental age-related effects and AD genetic risk. This will involve comparison across a
broad age spectrum, including molecular profiles of young controls (aged 18-35) and AD patients. Aim 3 will
characterize the interplay between CR and neurodegeneration in genetically diverse AD mouse models. This
will provide insight into the pathways mediating lifespan-increasing interventions in the brain, their interaction
with high-risk and resilient genetic backgrounds, and their overlap with AD risk and resilience pathways in hu-
mans. Importantly, this proposal will directly address the connections between lifespan and AD resilience to
provide a more nuanced understanding of the potential of CR and its mimetics as therapeutic strategies for AD.
This proposal employs an innovative research approach combining observational and interventional study de-
signs with state-of-the-art computational techniques. This approach facilitates concurrent human and mouse
data analysis, expediting the discovery of molecular pathways mediating AD risk and resilience, with potential
implications for developing novel AD prevention strategies. Under the mentorship of Dr. Harari and co-mentors
Dr. Goate, Kaczorowski, Karch, and Lee, I will follow a rigorous training program to meet the aims of this K99/R00
award and transition into independent research leadership in the domain of AD and aging. This will include a
focus on neurobiology, the biology of aging, mouse models of AD, bioinformatics, and professional development,
achieved through courses, workshops, conferences, and advisory committee feedback. In summary, this pro-
posal addresses a critical gap in our understanding of AD and aging, with the additional skills acquired during
this award laying a solid foundation for my future independence in the molecular biology of AD.

Public health relevance
Project Narrative Alzheimer’s disease is a complex neurodegenerative disorder with overwhelming personal, societal, and economic burdens for which there is currently no means of prevention or disease-modifying treatments. In this proposal, I will use multi-omic analyses in observational and interventional studies of human and mouse models of AD to systematically characterize molecular pathways associated with Alzheimer’s genetic risk and resilience. Completing this proposal can identify causal genetic variants of Alzheimer’s disease that have not been previously resolved using traditional genetic approaches and prioritize genes and pathways for drug development.